SAFETY AND PHARMACOKINETICS OF HPMPC IN HIV INFECTED PATIENTS

Determine the safety, tolerance, pharmacokinetics, and bioavailability of HPMPC when given as single doses by the oral, subcutaneous, and intravenous route to HIV-infected subjects.